A telehealth intervention to improve initiation of mental health treatment among depressed older adults with cancer

PROJECT ABSTRACT
Older adults with cancer (OACs) are a large and growing population with high levels of depressive symptoms
that are associated with greater morbidity and mortality. Despite widespread implementation of distress
screening procedures in cancer care settings, approximately half of distressed OACs do not receive mental
health services, in part because 50-75% of cancer patients decline mental health referrals and implementation
of evidence-based interventions is poor. As a result, the resources invested in distress screening do not lead to
improved patient care or reduced distress. Tools are needed to help depressed OACs initiate mental health
treatment. Pilot work by Dr. Trevino (PI) identified unique barriers to mental health care in OACs (e.g., burden
of multiple medical appointments) and needs of OACs (e.g., remote delivery to reduce travel burden). Dr. Sirey
(Co-I) developed an efficacious intervention titled Open Door that improves mental health treatment initiation in
depressed homebound older adults. Based on this prior work, the proposed study aims to modify Open Door
for OACs, evaluate Open Door in OACs (Open Door for Cancer; OD-C) to improve rates of mental health
treatment initiation in depressed OACs, and identify OD-C implementation strategies. The goals of this study
are to: (1) modify Open Door for OACs; (2) evaluate the feasibility and acceptability of OD-C in OACs; (3) test
the preliminary efficacy of OD-C on rates of mental health treatment initiation; (4) explore intent to initiate
mental health treatment, time to treatment initiation, and potential mediators of OD-C; and (5) identify multi-
level factors influencing implementation of OD-C. To meet these goals, we will conduct focus groups with
OACs and medical and psychosocial oncology providers (n=6 groups; n=6-8 participants per group) to identify
intervention modifications for OACs and cancer care settings. We will then pilot test OD-C in a randomized
controlled trial in which n=100 OACs are randomized to OD-C or Usual Care and assessed at baseline and 6-
and 12-weeks post-randomization to examine the feasibility, acceptability, and preliminary efficacy of the
intervention on rates of mental health treatment initiation. Further, we will explore the impact of OD-C on intent
to initiate mental health treatment and time to mental health treatment initiation and potential mediators
informed by the Health Belief Model (i.e., perceived severity of distress, perceived barriers to mental health
treatment, perceived benefits of mental health treatment, self-efficacy, and cues to action). In addition, we will
collect feedback from OACs who participate in OD-C (n=30) and oncology providers (n=30) on implementation
barriers, facilitators, and strategies. Grounded in the Health Belief Model, this study builds on prior work in
geriatric mental health and investments in distress screening in cancer care to address a gap in the mental
health care of OACs. These results will inform a future NIH R01 application to conduct a multi-site trial of OD-C
that considers patient characteristics, mechanisms of change, and implementation outcomes (i.e, reach).

Public health relevance
PROJECT NARRATIVE The proposed research is consistent with the broader public health goal of improving the mental health and quality of life of cancer patients, the majority of whom are older adults ( ≥65 years old) and with the College of Surgeons Commission on Cancer requirement that cancer care settings screen for patient distress and provide appropriate mental health care. The proposed study will address this public health issue by evaluating a brief intervention to improve rates of mental health treatment initiation in depressed older adults with cancer and identifying implementation strategies for this intervention. This study aligns with the NCI’s long-term goal of improving the mental health of older cancer patients and reducing the morbidity and mortality associated with untreated depression by ensuring that recent investments in distress screening result in improved mental health care of this population.